Characterization of Retinoid-Binding Protein 3 (RBP3): A Protective Factor Against Diabetic Retinopathy Identified in People with Extreme Diabetes Duration

PROJECT SUMMARY/ABSTRACT
Although treatment exists for late-stage diabetic retinopathy (DR) and macular edema, interventions to inhibit
DR onset and worsening, other than glycemic control, have generally not been successful. To identify novel
DR therapeutic targets, we studied Joslin 50-Year Medalists (N=1019), all of whom have type 1 diabetes
(T1D) for 50-87 years. The presence of DR protective factors is supported by a bimodal distribution of DR in
this cohort; 41% of Medalists have no-mild DR and 47% have quiescent proliferative DR (QPDR) despite no
significant difference in glycemic control. Longitudinal data for up to 60 years shows that Medalists protected
from proliferative DR (PDR) did not experience DR worsening after their first 17 years of diabetes. Mass
spectrometry of post-mortem retina and vitreous found a novel protective factor, interphotoreceptor retinol-
binding protein 3 (RBP3), to be elevated in Medalists with no-mild DR despite poor glycemic control. Our
paper in Science Transl. Medicine (2019) confirmed that RBP3 is elevated in the retina and vitreous of
Medalists with no-mild DR versus Medalists and non-Medalists with QPDR, and that RBP3 in the retina and
vitreous of diabetic individuals is lower than in non-diabetic controls. RBP3 overexpression in in vivo studies
by lentivirus subretinal injection, embryonically by transgene targeting photoreceptors or intravitreous
injection of recombinant RBP3, inhibited retinal VEGF and IL-6 expression and normalized vascular
permeability, electroretinogram changes and acellular capillaries in diabetic rodents. Mechanistic studies
showed that in Muller and endothelial cells, RBP3 binds to cell surface proteins including GLUT-1 to decrease
glucose uptake and glycolytic flux, neutralizing adverse actions of hyperglycemia. We developed a sensitive
and specific ELISA assay that showed RBP3 levels in the vitreous and serum (at 1/1000 of vitreous levels)
were correlated with each other and with DR severity, and inversely correlated with vitreous VEGF. RBP3
expression in photoreceptor cells was reduced by high glucose, possibly due to protein kinase C (PKC) δ
activation and inhibition of serum reactive factor (SRF) transcription factor via the Akt pathway. Preliminary
studies of RBP3 subdomains show structure-function activities for inhibiting glucose uptake by binding to
GLUT-1 transporters and reducing VEGF and IL-6 expression in Muller cells. The specific aims proposed
are: Sp. Aim 1: To characterize and compare RBP3 levels in the retina, vitreous and serum as a potential
biomarker for DR in T1D and T2D patients at the Joslin Diabetes Center, with validation in the Finland
FinnDiane T1D cohort and DRCR Protocol T (T2D) cohort. Sp. Aim 2: To determine the mechanism for
hyperglycemia-induced downregulation of RBP3 expression in photoreceptors in vivo and in a photoreceptor
cell line by activation of PKCδ and deactivation of the Akt/mTOR/S6K pathway and SRF transcription factor.
Sp. Aim 3: To define structure-function relationships between the RBP3 full length protein and its
subdomains with regard to interaction with GLUT-1 and glucose uptake in Müller and retinal endothelial cells.

Public health relevance
PROJECT NARRATIVE In studies involving the Medalist cohort, composed of people with insulin-dependent diabetes for ≥50 years, as well as their donated retinal tissues, we have identified a retina-specific protein, retinol binding protein 3 (RBP3), which can neutralize the toxic effects of hyperglycemia and diabetes on the retinal tissues and blood vessels. In this application, we will evaluate whether retinal and serum RBP3 levels correlate with severity of diabetic retinopathy in a wide range of patients, and investigate the regulation of its expression and its protective mechanisms on retinal cells. These findings have identified RBP3 as a potential new therapeutic agent for diabetic retinopathy.